Activation Mechanism of Soluble Guanylate Cyclase

Nitric oxide (NO) signaling is essential to several physiological functions, and dysfunction in the
in this signaling cascade is implicated in multiple diseases such as erectile dysfunction, heart
disease, neurodegeneration, stroke, hypertension, and gastrointestinal disease. Soluble
guanylate cyclase (sGC) is the primary receptor for NO. NO regulates sGC at two levels and
this is consistent with pharmacological observations of NO signaling that are consistent with a
two-step activation mechanism by NO. The amplitude and duration of these effects of NO in
neuronal signaling, cardiac function, vascular tone and vasodilation are vital to proper function,
but the mechanism for the two-step activation by NO has not been thoroughly investigated. A
new paradigm for NO signaling through sGC has emerged. Understanding how sGC switches
from a low to high activation state is central to this new paradigm. In addition, sGC has become
a therapeutic target for the treatment of two forms of pulmonary hypertension: chronic
thromboembolic pulmonary hypertension and pulmonary arterial hypertension with the FDA
approved Adempas®. Our specific aims include: (i) How does NO activate sGC?, (ii) What is
the structural architecture of full-length sGC and what are the inter-domain interactions that
contribute to the activation mechanism of sGC?, and (iii) What is the mechanism of action of
Adempas® (riociguat) and related stimulators of sGC. Experimental approaches will include the
following biochemical methods: enzyme kinetics, cloning, expression, purification and
characterization of wild type and site-directed mutants of sGC, electron microscopy structural
methods, hydrogen-deuterium exchange and peptide mapping. It is a central goal of this
proposal to develop a complete molecular level view of the complex relationship between NO,
drugs like Adempas® and sGC. The extension of this work into physiological function will
provide a rational basis for the understanding and treatment of NO signaling disorders in human
disease.

Public health relevance
The enzyme soluble guanylate cyclase (sGC) is activated by the endogenous vasodilator nitric oxide. FDA approved drugs such as Adempas® directly stimulate this enzyme and synergize with nitric oxide in the treatment of cardiovascular disease. The proposed studies will determine how nitric oxide activates sGC and the mechanism of action of drugs like Adempas®.